Vascular niche restoration to prevent delayed effects of acute radiation exposure (DEARE) in the hematopoietic system

Project Summary
For survivors of acute radiation sickness (ARS), the delayed effects of acute radiation exposure
(DEARE) can affect multiple organs over time, leading to chronic degenerative diseases and
increased risk of cancer. Perhaps no organ system is more profoundly at risk for life threatening
DEARE than the hematopoietic system. Multiple longitudinal studies of the Hiroshima and
Nagasaki atomic bombing survivors cohort have demonstrated that the highest radiation-
induced cancer risk was for leukemia, which had the highest cancer frequency and impact on
atomic bomb survivor mortality within the first 10 years after the bombings. Additional studies
confirmed an increased incidence of myelodysplasia, a pre-leukemic state in the hematopoietic
system, in survivors of the Nagasaki bombing, with elevated risk persisting for up to 60 years.
Emergency cleanup workers from Chernobyl similarly suffered increased incidence of acute
leukemia during the first 11 years after the accident. Animal studies have demonstrated that
single gamma radiation exposures cause persistent DNA damage and apoptosis in long-term
hematopoietic stem cells (LT HSCs) and depletion of HSCs capable of reconstituting
hematopoiesis. We hypothesize that therapeutic restoration of the bone marrow (BM) vascular
niche, wherein HSCs reside, after ARS will facilitate the regeneration of long-term HSCs and
prevent ongoing radiation-induced damage to the hematopoietic compartment. Research over
the past decade has confirmed that long-term HSCs depend upon paracrine signals from BM
endothelial cells (BM ECs) and perivascular stromal cells for their maintenance and
regeneration following radiation injury. Furthermore, BM ECs regulate the maintenance of HSC
genomic integrity, HSC DNA repair and inflammatory mechanisms in the niche. We have
discovered that inhibition of SEMA3A – Nrp1 signaling in BM ECs blocks radiation-induced BM
EC apoptosis after ARS and accelerates restoration of the intact BM vascular niche in irradiated
mice. In this project, we will test whether inhibition of Nrp1 signaling and early restoration of the
healthy BM vascular niche can prevent the delayed adverse effects of radiation on the
hematopoietic system: HSC depletion, BM failure, clonal hematopoiesis and leukemia. Our
preliminary data suggest that Nrp1 inhibition markedly augments the early recovery of the most
primitive SLAM KSL HSCs in irradiated mice, suggesting that this mechanism can mitigate
radiation-induced HSC depletion following ARS. When combined with GCSF, Nrp1 inhibition has
the potential to broaden our therapeutic horizon beyond ARS and to mitigate ominous delayed
effects, including BM failure, myelodysplasia and leukemic transformation.

Public health relevance
Project Narrative Delayed effects of acute radiation exposure to the blood system can be severe, including failure of blood production and transformation to leukemia. Blood stem cells depend on signals from nearby blood vessels, the “vascular niche”, for survival and regeneration after injury. We will test whether therapeutic restoration of the damaged vascular niche can prevent blood system failure and development of leukemia over time following acute radiation injury.